Myelofibrosis impacts the hematopoietic niche through TNF-a

Project Summary/Abstract
Myeloproliferative neoplasms (MPNs) are a clonal expansion of hematopoietic cells, and progression
leads to deposition of collagen fibers throughout the blood-forming spaces of the bone marrow. In advanced
cases, this causes bony replacement of the marrow cavity, blood maturation outside the bone marrow
(extramedullary hematopoiesis), and transformation to fatal acute leukemia. Stromal cells normally form a
hematopoietic niche to support hematopoietic stem cells, but in MPNs these cells are reprogrammed to produce
overwhelming collagen. We dissected the signals from abnormal hematopoietic cells in MPNs that target bone
marrow stromal cells, disrupting their ability to support normal hematopoiesis. We recently reported that
transforming growth factor-J3 (TGF-J3) promotes collagen deposition and suppresses expression of key niche
factors by bone marrow stromal cells. Moreover, blockade of TGF-J3 signaling in stromal cells can reverse bone
marrow fibrosis in mouse models of MPN. However, when TGF-J3 signaling is blocked there is still disruption of
the hematopoietic niche and development of extramedullary hematopoiesis. To identify additional signals that
disrupt the hematopoietic niche in MPNs, I isolated stromal cells from patient bone marrow samples and identified
candidate signaling pathways that alter the bone marrow microenvironment. Based on these data, I hypothesize
that tumor necrosis factor-alpha (TNF) and platelet-derived growth factor (PDGF) contribute to loss of niche
factors. In Aim 1, I will define the role of PDGF receptor signaling in bone marrow stromal populations in MPNs.
Using mouse models to abrogate signaling through the two PDGF receptors in bone marrow stromal cells, I will
transplant mouse cells with MPL w515
L or JAK2v61 7
F mutations to model MPNs. I will assess hematopoietic
stem/progenitor cells, extramedullary hematopoiesis, niche factor expression, fibrosis, and survival. In Aim 2, I
will define the role of TNF receptor signaling in bone marrow stromal populations in MPNs. I will abrogate TNF
signaling through the two TNF receptors in stromal cells and use MPN transplant models to assess the impact
on hematopoietic stem/progenitor cells, niche factor expression, extramedullary hematopoiesis, and fibrosis.
Achieving these aims will improve our understanding of alterations in the bone marrow microenvironment through
TNF and PDGF that lead to disease progression in MPNs. These insights will refine therapeutic targeting for
more effective interventions to improve outcomes for patients. The overall goal is to establish an independent
research laboratory studying contributions of the bone marrow microenvironment to normal and malignant
hematopoiesis. This proposal outlines a five-year training plan to acquire advanced skills including innovative
approaches in hematopoiesis and MPNs. The primary mentor is Dr. Daniel Link, a distinguished scientist in
hematopoiesis, bone marrow microenvironment, and myeloid neoplasms, with a committee of Drs. Tim Ley,
Stephen Oh, and Grant Challen for scientific and career development advising. Washington University is an
exceptional environment for training with strong collaborations to gain expertise in stem cell biology and MPNs.

Public health relevance
Project Narrative This proposal outlines an approach to advance our understanding of how cells that support normal blood formation are changed in patients with a hematologic disease called myeloproliferative neoplasms. We will test the hypothesis that changes in interactions between cells in the bone marrow microenvironment cause low blood counts and enlarged spleen size through tumor necrosis factor-alpha (TNF-α) and platelet derived growth factor (PDGF). This preclinical research may lead to new combinations of therapies for clinical trials in patients with myeloproliferative neoplasms to prevent development and worsening of disease.